Training in Molecular and Systems Toxicology

Abstract
The proposed University of Colorado Anschutz Medical Campus T32 training program in Molecular and
Systems Toxicology (MST) provides a multi-disciplinary research mentorship program centered around training
in systems toxicology including genomics/epigenetics, proteomics, and metabolomics as well as molecular
approaches to understand underlying mechanisms of toxicity. The proposed T32 training program will be
housed under the multi-institutional Toxicology and Pharmaceutical Sciences graduate programs which are
based within the Department of Pharmaceutical Sciences, Skaggs School of Pharmacy, but which includes
faculty from the Schools of Medicine and Public Health on the Anschutz Medical Campus and also includes
faculty from National Jewish Health. The proposed MST training program is requesting 2 predoctoral
positions/year for 2 years of support (in years 3 & 4 for a total of 8 predoctoral trainees over 5 years). The
proposed University of Colorado Anschutz Medical Campus MST training program will be supported by 16
faculty which are focused on systems toxicology research and are listed as mentors on this T32 application.
This training program has the primary goal and responsibility of developing predoctoral students into
independent and successful environmental health scientists with expertise in systems toxicology. This goal will
be achieved by utilizing: 1) internationally recognized, well-funded research mentors in systems toxicology; 2)
outstanding institutional support from the UC Anschutz campus; 3) targeted didactic learning approaches; 4)
training in responsible conduct in research, grant writing and career development; 5) continued excellence in
recruitment and enhancement of diversity; 6) continued student engagement in research, education and career
development through various programs; 7) continual development of systems toxicology related coursework
and experiences; 8) evaluation metrics to continually improve the UC Anschutz MST training program.
Ultimately, we expect our trainees to develop into independent scientists with the knowledge and skills to
address challenges in toxicology and environmental health using cutting edge `omics' and `big data'
approaches.

Public health relevance
Project Narrative This application requests the establishment of a new predoctoral training program at the University of Colorado Anschutz Medical Campus in Molecular and Systems Toxicology. The program requests stipend and tuition support for 2 predoctoral trainees in years 3 & 4 of their training (for a total of 8 predoctoral trainees over 5 years). The mission of this training program is to develop students into independent scientists that have skills and knowledge to utilize cutting edge research approaches in `omics' technology to address problems presented by complex exposures to environmental agents, drugs and therapies.